Molecular mechanisms of gasdermins and pyroptosis

Contact PD/PI: Xiao, Tsan Abstract The inflammasomes are crucial innate immune signaling platforms implicated in immune defense against infections and autoimmune/autoinflammatory disorders such as multiple sclerosis, diabetes, and Alzheimer’s disease. Pyroptosis is triggered by inflammatory caspases-­1, 4, 5, or 11 upon stimulation of the canonical and noncanonical inflammasomes. Despite the recent progress on the identification and characterization of GSDMD as an effector of pyroptosis, the molecular events underlying the transformation of GSDMD from an autoinhibited resting state to the recognition and cleavage by caspases has remained poorly defined. The lack of mechanistic understanding of GSDMD-­mediated pyroptosis has hampered progress on the development of novel therapeutics against infections and autoimmune/autoinflammatory disorders. This proposal targets critical gaps in our understanding of GSDMD/inflammatory caspase-­mediated pyroptosis using complementary structure-­ function approaches. We hypothesize that GSDMD is maintained in an autoinhibited conformation through intramolecular domain interactions between its N-­ (GSDMD-­N) and C-­terminal (GSDMD-­C) domains. Such conformation is recognized by inflammatory caspases that cleave at the linker region to release the autoinhibition and facilitate membrane pore formation. We propose the following specific aims to test the above hypothesis. Aim 1. Define the mechanism through which GSDMD maintains its autoinhibited state, and how such autoinhibition may be regulated by small molecule tool compounds. We will characterize the structure of the GSDMD domains and the full-­length protein in its autoinhibited state using primarily structural approaches, in concert with analysis of the GSDMD-­N and GSDMD-­C interactions through biochemical techniques. The role of the intramolecular domain interface during Salmonella infection-­induced pyroptosis will be probed using GSDMD-­deficient cell lines reconstituted with mutant GSDMD. A unique feature of our approach is the incorporation of GSDMD-­binding compounds identified from chemical libraries screening into the above efforts to investigate the regulation of GSDMD and pyroptosis by small molecule tool compounds. Aim 2. Define the mechanisms of gasdermin recognition and cleavage by inflammatory caspases. We will elucidate the molecular basis of the conversion of caspases-­4 and 11 from zymogens to active conformation, which has been poorly characterized. We will investigate the mechanism of GSDMD recognition by these caspases, which may involve both the linker peptides and tertiary structure of GSDMD. In summary, this project will delineate the molecular mechanisms underlying the autoinhibition and activation of GSDMD during pyroptosis, identify small molecule tool compounds and characterize their mode of action in the context of pyroptosis regulation. This will not only furnish unique insights on GSDMD structure and function, but may stimulate the development of therapeutics that target inflammatory disorders. Project Summary/Abstract Page 6

Public health relevance
Contact PD/PI: Xiao, Tsan Relevance Inflammasomes play important roles in immune defense against infections and autoimmune/autoinflammatory disorders such as multiple sclerosis, diabetes, and Alzheimer’s disease. Pyroptosis is a highly proinflammatory form of cell death that functions as a crucial immune defense mechanism in microbial killing and clearance. By contrast, uncontrolled systemic pyroptosis plays a major role in septic shock. The success of this project will not only provide insights into the molecular mechanisms of GSDMD autoinhibition and activation, but may also stimulate the development of therapeutics that target inflammatory disorders, as well as novel antimicrobial reagents that combat the global antibiotic- resistance epidemic. Project Narrative Page 7